Disentangling Self-Avoidance

SUMMARY
Dendrites are the fine, and often highly branched, processes through which neurons receive information from
their environment. The morphologies of dendrites are important for connectivity and healthy functioning of the
nervous system. Thus, it is critical to understand the genes that control dendrite morphogenesis and
maintenance. One key broadly conserved feature of dendrite and axon morphology is their even spreading
across territories without overlap. Repulsion between arbors of the same cell, termed self-avoidance, is under
the control of two major pathways in Drosophila somatosensory neurons, a powerful model for studies of
dendrite morphogenesis. One pathway supports dendrite-dendrite recognition and repulsion and is mediated
by Down syndrome cell adhesion molecule 1 (Dscam1). In the absence of this pathway, dendrites cross each
other and become tangled, leaving parts of their receptive field uncovered and other parts over-innervated.
Another pathway that impacts whether dendritic membranes are available for contact and recognition is
mediated by integrin receptors for the extracellular matrix. In the absence of this pathway, dendrite-substrate
interactions predominate and dendrites become enclosed by membranes of nearby cells. It is important to
discriminate between these two pathways so that the molecular basis for dendrite development can be better
understood. However, we still have relatively few insights into how different genes impact these two pathways,
so both dendrite-dendrite and dendrites-substrate interactions are not well known. As a result, the potential for
these studies to inform our understanding of more complex mammalian systems has not been fully realized.
We will use a simple but powerful technique for assaying dendrite-substrate interactions to build a clearer
understanding of self-avoidance pathways. We expect that the insights gained can inform us about the
development of more complex brains that are more similar to own.

Public health relevance
PROJECT NARRATIVE Dendritic arbors are the input regions of neurons and their morphologies are critical for neuronal circuit connectivity and function. This project will address the molecular basis for a broadly conserved feature of dendrites termed self-avoidance, in which dendrites spread to cover their inputs without overlap. Given that multiple disease states are characterized by abnormal dendritic arbor morphology, we expect our results will be important for understanding healthy and diseased brain function.